Early Origins of Chronic Lung Disease: From Birth to Age 45 Years

PROJECT SUMMARY: Asthma, chronic obstructive pulmonary disease (COPD) and the Preserved ratio
impaired spirometry (PRISm) are associated with increased morbidity and mortality across the lifespan. Recent
discoveries strongly suggest that the roots of many cases of these three heterogeneous conditions can be
found in early life. Identifying the lifetime molecular pathways underlying them will provide a new understanding
of the pathogenic mechanisms involved in their inception. The Tucson Children’s Respiratory Study (TCRS) is
a birth cohort that has already made major contributions to our understanding of the natural history of lung
function trajectories and the early origins of asthma and COPD. A recent tantalizing result was derived from the
use of lung function measurements obtained repeatedly from early childhood through the beginning of the 5th
decade of life to model latent class trajectories in over 600 participants. We identified a novel resilient
trajectory, in which lung function decline occurs at a slower rate than in their peers. Early data suggests that
this resilience may be afforded through increased lung protective antiproteases molecules. We also identified
individuals with dysanapsis, i.e., disproportionate scaling of airway dimensions to lung volume, which is a risk
factor for COPD. A strong precursor of dysanapsis was excessive weight gain between infancy and the early
school years and we found a specific serum biomarker at age 6, PTX2, that may mediate this association. We
showed that restrictive spirometry is associated with poor prenatal and early life growth and detected early life
developmental modules that may be responsible for these differences. We identified phenotypes related to the
natural history of asthma, and linked these to novel metabolic pathways that may be responsible for the onset
or persistence of asthma. TCRS participants are in the 5th decade of life, when lung function changes
associated with chronic lung disease become increasingly more apparent. In this application, we have adapted
new technologies, such as gold standard metabolomics, proteomics, and single-cell and bulk RNA sequencing,
applied to longitudinally collected samples, in combination with ongoing assessment of the participants. Using
these technologies, we will investigate, prospectively, the early risk factors for these lung disorders at the
molecular level. We will address three specific aims: 1. To continue following TCRS participants to further
characterize different lung function trajectories and phenotypes from childhood into adult life, and to specifically
assess the molecular underpinnings of lung dysanapsis and of the obstructed and resilient trajectories. 2. To
identify profiles in the serum proteome and peripheral blood gene expression patterns associated with poor
postnatal somatic growth, and to relate these profiles to the restricted spirometric trajectory. 3. To characterize
the novel cellular and molecular mechanisms underlying the natural history of asthma. As the only birth cohort
with hundreds of non-selected participants followed from birth into the fifth decade of life, the TCRS offers a
unique opportunity to investigate the longitudinal mechanisms underlying these lung disorders.

Public health relevance
PROJECT NARRATIVE Asthma, chronic obstructive pulmonary disease (COPD) and a restrictive spirometry pattern, which are strongly associated with increased morbidity and mortality, have their roots in early life. The Tucson Children’s Respiratory Study (TCRS) is a birth cohort that has already made major contributions to our understanding of the natural history of lung function trajectories and subtypes of asthma, including by identifying a novel pattern of lung function resilience and risk factors for asthma remission and adolescent/adult onset. With new technology applied to longitudinally collected samples, and ongoing assessments of the participants in their 5th decade of life, we are poised to investigate, prospectively, the early risk factors for these lung disorders at the molecular level.